PATHOLOGY SUPPORT FOR TOXICOLOGY TESTING PROGRAM

Provide pathology support to the Toxicology Research and Testing Program. Support will include evaluating pathology materials; making histology, necropsy, and histopathologic interpretations; chairing or serving as a member of NTP Pathology Working Group Sessions; performing other special projects such as developing grading criteria for toxic lesions, preparing slide study sets, correlating toxic lesions from subchronic studies with neoplasms from two-year studies; and participating in histopathology conferences or NTP Annual Roundtable Sessions.